CRCNS:NeuroBridge: Connecting Big Data for Reproducible Clinical Neuroscience

PROJET ABSTRACT
No changes from original proposal.

Public health relevance
PROJECT NARRATIVE No changes from original proposal.